Harnessing High-Resolution Proteomics to Uncover and Target Neoepitopes in Sjogren's Disease

ABSTRACT
Sjögren’s Disease (SjD) is a chronic autoimmune disorder characterized by the infiltration of lymphocytes into
the salivary and lacrimal glands, leading to significant inflammation and resultant glandular dysfunction. This
pathology manifests primarily as dry mouth and eyes but can also involve other organs and cause systemic
symptoms. The disease predominantly affects postmenopausal women, although it can occur in all age groups
and genders. The precise mechanisms that trigger the immune system to attack these glands are not well
understood, but the presence of specific autoreactive T cells and autoantibodies suggests a complex interaction
of genetic, environmental, and immunological factors. Understanding these underlying mechanisms is crucial for
developing targeted therapies and preventative strategies. This project aims to advance our understanding of
SjD by focusing on the in-situ identification and characterization of neoantigens (NeoAg) and neoepitopes
(NeoEpt) generated by post-translation modification (PTM) within the salivary glands. We hypothesize that the
unique microenvironment within the salivary glands, influenced by inflammatory processes, fosters the
generation of distinctive NeoAg and NeoEpt. These PMT NeoEpt likely interact preferentially with predisposing
HLA molecules in susceptible individuals. Disrupting these critical NeoEpt/HLA interactions represents a novel
and potentially transformative approach to mitigating the progression of SjD. To explore this hypothesis, we have
structured our objectives into three concurrent aims to maximize efficiency and impact: Aim 1 involves the
ultrasensitive deep proteome profiling of salivary glands from murine models and human patients with
SjD. This aim focuses on discovering and cataloging PTM-peptides using state-of-the-art high-resolution
proteomics technologies to ensure detailed and accurate analyses. We anticipate identifying novel candidate
neoantigens that exhibit unique PTM signatures, potentially indicative of the early stages of the disease. Aim 2
concentrates on mapping and characterizing the interactions between these peptides and HLA
molecules predisposing individuals to SjD. Through advanced molecular modeling and HLA binding
predictions, this aim will define the affinity and stability of peptide-HLA (pHLA) complexes, pinpointing those most
likely to initiate an autoimmune response. This effort will enhance our understanding of antigen presentation in
SjD and may identify potential therapeutic targets. Lastly, Aim 3 assesses the therapeutic potential of
targeting these neoantigen presentations. Utilizing a novel humanized HLA-DR3 SjD model and primary T
cells from patients, this aim tests the effectiveness of small molecule inhibitors that disrupt critical NeoEpt/HLA
interactions, thereby exploring new treatment avenues for SjD. The successful execution of these aims is
expected to produce a first-of-its-kind comprehensive database of salivary gland NeoEpt, serving as a valuable
resource for the scientific community. Additionally, it will validate novel functional NeoEpt in situ, provide
significant mechanistic insights into the initiation of SjD, and highlight preventive strategies for at-risk individuals.

Public health relevance
PROJECT NARRATIVE This project investigates Sjögren’s Disease (SjD) by focusing on the in-situ identification and characterization of neoantigens and neoepitopes within the salivary glands, aiming to understand the autoimmune triggers at a molecular level. Utilizing advanced proteomic technologies, the study seeks to map interactions between these molecular markers and HLA molecules, potentially identifying new therapeutic targets. Ultimately, the project aims to develop personalized treatment strategies based on disrupting these critical interactions, thereby offering innovative approaches to mitigate the progression of SjD. 1